Carolinas United to End HIV Scientific Working Group

The Carolinas United to End HIV (CUE-HIV) Scientific Working Group (SWG) was formed in 2021 through a
merging of the CUE-HIV interest group and the Collaborative HIV Epidemiology and Prevention SWG.
CUE-HIV is an interstate collaborative created to address the disproportionate HIV burden in the Carolinas driven by our states’ unique intersection of poverty, and limited resource allocation. Our initiative employs a multifaceted strategy designed to promote awareness, expand funding, and improve resource availability with one ultimate goal: ending the HIV epidemic in the Carolinas. We believe that our united front will prove far more impactful than the sum of our individual parts. We are a collaboration between North and South Carolina and have built on the strengths of the investigators in our cross-state collaboration. Our partner institutions include Wake Forest University, UNC Charlotte, the Mecklenburg County Health Department, the South Carolina Department of Health and Environmental Control, the North Carolina Department of Health and Human Services, the University of South Carolina, and the Medical University of South Carolina.